Administrative Core (Core A)

Administrative Core - PROJECT SUMMARY
The Tennessee Center for AIDS Research (CFAR) is a four-way partnership between a research-intensive
institution (Vanderbilt University Medical Center, VUMC), a historically black medical college (Meharry Medical
College, MMC), an academically-engaged state health department (Tennessee Department of Health, TDH),
and a sophisticated community-based organization with a 25-year exclusive focus on HIV (Nashville CARES).
To achieve the overall aims of the CFAR and its cores requires an innovative, flexible, and engaged
Administrative Core (AC). The significance and impact of the AC is heightened by the multi-institutional structure
of the CFAR, making its work critical to the success of the program. The AC will add value to the significance of
HIV research at our partnered institutions by providing leadership and resources for collaborations that will
impact the field. The work of the AC is grounded in transparent communication, maximizing efficient use of
financial and human resources, and serving the needs of HIV researchers across our diverse institutions. The
AC is the “operating system” of the CFAR, overseeing resources and creating a collaborative environment for
CFAR members. The AC will support the entire CFAR enterprise by pursuing four specific aims: 1) To provide
leadership, management, coordination, and supervision of CFAR activities; 2) To enhance the HIV research
productivity of CFAR investigators by supporting and coordinating collaborative and trans-disciplinary
approaches; and 3) To facilitate effective and bi-directional communication about HIV-related research
resources, activities and advances. The CFAR leverages Vanderbilt's strength in developing biomedical
informatics tools to support research operations. The AC will leverage such biomedical informatics tools to
support CFAR operations through real-time data collection for continuous quality improvement. This empowers
the AC and CFAR to efficiently provide institutional leadership in HIV, needed core services for CFAR
investigators, and mentoring of future leaders in HIV research.